Oregon Spina Bifida Registry Project-Comp B

PROJECT SUMMARY/ABSTRACT
Spina bifida is the most common permanently disabling birth defect in the United States
and requires complex and long-term medical care. Enhanced understanding of care
practices of spina bifida programs and about health outcomes will improve outcomes
and quality of life experiences for persons living with spina bifida. Evidence from other
complex and chronic conditions has shown that a National Spina Bifida Patient Registry
allows for comparison of outcome data among care centers and identification of
strategies to improve outcomes. Assessment by the Spina Bifida Association in
collaboration with other groups identified need for a national infrastructure to support
clinical research and a systematic approach to improving quality of care for people with
spina bifida. This project will facilitate continued implementation and refinement of a
national spina bifida patient registry. OHSU has a long history of addressing systems of
care for people with spina bifida, including participation in the national registry efforts
since their inception, and this project builds on experience that includes systematic
collection and evaluation of clinical data.
This project contributes to building the clinical evidence base about current health
practices in spina bifida care and health outcomes; this evidence is needed to aid
development and adoption of national standards of care for people with spina bifida that
can be applied to reduce disparities and improve health outcomes across clinics,
populations, and regions of the US. The primary objective of this application is to extend
participation in the National Spina Bifida Patient Registry via utilization of the
standardized registry tool to collect data from patients with spina bifida. A complete
source for spina bifida patient data will make it possible to compare treatments and
outcomes of populations and identify areas for future research to guide best clinical
practices and improve the lives of persons living with spina bifida. Continued
participation in the project will emphasize ongoing collection of data on participating
patients. Further, project personnel will collaborate with professionals at other sites
participating in the registry to analyze obtained data and disseminate findings.

Public health relevance
PROJECT NARRATIVE The proposed project involves continued involvement in the National Spina Bifida Patient Registry by continuing to collect registry information on all eligible patients with Spina Bifida enrolled in the project and sharing that information with the CDC. Additionally, we will continue to implement strategies to integrate documentation of registry data during standard clinical practice, and will evaluate methods of electronic extraction of these data. Finally, we will contribute to the analysis of data gathered through the project, as well as dissemination of findings via presentation at professional conferences and publication in peer-reviewed journals.